Coregulation of genes by pioneer transcription factors and noncoding RNAs

Project Summary
Spatial and temporal co-regulation of genes is essential for development and prevents the formation of
disease states from cancer to neurodegeneration. Despite decades of research, the mechanisms by which
any specific group of target genes is co-regulated at the right time and place remain unknown. To
mechanistically understand how co-regulation of genes is achieved, my research program defines new
combinatorial rules for precise spatial and temporal coregulation. Revealing the rules that drive
coregulation of specific subsets of genes is highly significant because it advances our understanding of gene
expression across space and time which has the potential to ultimately enable the correction of misregulated
gene expression in disease contexts.
To reveal the rules that govern the co-regulation of specific subsets of genes, it is essential to understand
how different classes of regulatory factors function together to co-regulate the correct target genes spatially
and temporally. Two key classes of factors that we and others have determined co-regulate the same groups
of genes across species are: 1) DNA-binding transcription factors (TFs) and 2) long non-coding RNAs
(lncRNAs). However, very little is known about how TFs and lncRNAs function together to regulate specific
groups of target genes.
Recently, we and others discovered that competition versus synergy between GA-binding pioneer TFs can
co-regulate distant genes by increasing the 3D proximity of tethering elements, a new conserved class of
gene regulatory element. LncRNAs also associate with tethering elements to co-regulate subsets of genes by
poorly understood mechanisms that may involve regulating 3D genomic contacts. Therefore, the function of
tethering elements is regulated by associating with both pioneer TFs and lncRNAs, but how these regulatory
factors function together to specifically target the correct group of genes for co-regulation is not understood.
We will answer the following key questions:
Question #1: How does competition between pioneer TFs with similar binding sites coregulate specific groups
of genes in 3D?
Question #2: How do interactions between pioneer TFs and lncRNAs coregulate specific groups of genes?
Question #3: How do pioneer TFs and lncRNAs coregulate specific groups of genes over time and space?
Our overall hypothesis is: Competition between GA-binding TFs and specific interactions between TFs
and lncRNAs combine to three-dimensionally link the correct regions of the genome for co-regulation of gene
expression over time and space. My research program will test this hypothesis by combining diverse
methods including genetics, genomics, biochemistry, single particle imaging, and new computational
approaches to define the combinatorial rules by which genes are co-regulated across space and time.

Public health relevance
Project Narrative Coordinated gene expression of the correct target genes is essential for all organisms and to prevent the formation of disease states from cancer to neurodegeneration. We will define the mechanisms by which pioneer transcription factors and long non-coding RNAs function together to coregulate genes across time and space in diverse cell types. By determining these new mechanisms for coordinated gene expression, we will inform efforts to correct misregulation of genes in disease contexts.